New Approaches to Inducing Cardiac Allograft Tolerance

PROJECT SUMMARY / ABSTRACT
Achieving tolerance, defined as long-term allograft survival in the absence of ongoing immunosuppression, is
the ultimate goal in transplantation. Tolerance of kidney allografts has been achieved in non-human primates
(NHPs) and in humans using a combination of non-myeloablative conditioning and donor bone marrow
transplantation (DMBT) that results in transient donor chimerism. However, until now, transient mixed-chimerism
protocols that achieve long-term tolerance of kidney allografts in NHPs have consistently failed to induce
tolerance in recipients of heart allografts. It is well known that some organs, such as kidney and liver, are
“tolerance-prone” while others, such as heart and lung, are “tolerance-resistant.” Despite the immune barriers
posed by the heart, our laboratory has recently developed novel protocols that have, for the first time, achieved
long-term, stable tolerance of heart transplants in cynomolgus monkey recipients. This remarkable result was
attained in heart recipients exhibiting only transient mixed chimerism by including donor kidney cotransplantation,
which enhanced the contributions of host regulatory T cells following mixed chimerism conditioning. While the
combination of kidney and heart transplantation produced remarkable results, this strategy does not have wide
clinical feasibility due to the use of experimental agents and the ethical barrier of sacrificing a kidney simply to
induce heart tolerance. Although lung allografts will not be studied in this Program, our recent findings in lung
recipients provide proof of principle that durable mixed chimerism can be achieved in NHPs and that this state
results in long term tolerance of resistant thoracic organs; these were the first NHPs to become tolerant of lung
allografts. Thus, the unifying goal of this overall Program is to design innovative mixed chimerism
strategies for heart alone recipients that either amplify the contributions of regulatory T cells and
macrophages in transient mixed chimerism protocols (Project 1) or achieve durable mixed chimerism
(Project 2) while using clinically-relevant agents for host conditioning (Project 3). Project 1 will focus on
enhancing the contribution of regulatory T cells and macrophages in protocols which induce transient mixed
chimerism. Project 2 will focus on achieving durable mixed chimerism using next-generation conditioning
regimens, innovative immunosuppression platforms. Project 3 will investigate novel, clinically-applicable, agents
which enhance costimulation blockade and diminish toxicity. Core A will investigate the mechanisms by which
treatments described in Projects 1-3 influence the host immune response. The Program will be organized in such
a way that early mechanistic discoveries/advances in Core A will inform and refine the aims of Projects 1-3. The
complementary models and approaches described in this application are unique strengths of this program
project. We anticipate that together, these highly interactive projects will generate one or more safe and effective
tolerance protocols that will be ready for clinical trial(s) in heart allograft recipients by the end of the funding
period.

Public health relevance
PROGRAM NARRATIVE Achieving long-term survival of organ transplants without the need for chronic immunosuppression will provide transplant recipients with a healthier and longer life. These studies will explore ways to eliminate the need for chronic immunosuppressive drugs in patients undergoing heart transplantation.